The microbiome in older adults with lung cancer: association of treatment regimens and diet with protective microbial profiles

PROJECT SUMMARY
The gut microbiome changes as humans age and affects many aspects of human health including response to
cancer treatments. Increased abundance of the microbe Akkermansia muciniphila has been shown to increase
response to immune checkpoint blockade (ICB), a class of anti-cancer agents enable the immune system to
identify and attack cancer cells. Rational manipulation of the microbiome is a promising approach to improve
cancer and other health outcomes, but as with many studies and trials, the effect of age is understudied. Older
adults remain poorly represented in clinical trials for ICB and interventions directed at the microbiome to
promote response to ICB. This is problematic because age has been shown to affect the microbiome.
Therefore, an intervention related to the microbiome will likely have to be tailored to older adults. In addition,
diet-based microbiome interventions are likely to enter clinical practice, but linking food intake to changes in
particular microbes has proven challenging.
My overall goal is to be an academic researcher studying the role of the microbiome in cancer care for
older adults, and how to use diet-based interventions to modify the microbiomes of older adults to promote
health. To this end, the objectives of this application are (1) identify the microbiomes of older adults who
respond to ICB, (2) modify the microbiome through diet-based interventions, and (3) verify the causal role of
the microbiome using preclinical models. To meet these objectives, this study will utilize data from ongoing
trials for which I am leading the microbiome collection, data generation and analysis efforts. First, these data
will help to define the microbiomes of older lung cancer patients who respond to ICB (SA1). Next, we will test a
black raspberry dietary intervention for its ability to promote a pro-ICB response microbiome in older adults
(SA2). Finally, pre- and post-intervention human microbiomes will be transferred into mice to assess the effect
on response to ICBs (SA3).
These aims will support a method for predicting which older adults will respond to treatment, suggest a
therapeutic strategy to increase healthspan, and improve our understanding of how the microbiome interacts
with the immune system in older adults. This award will provide me with the time to gather knowledge and
experience in fields outside my current training, especially clinical geriatrics and the cancer microbiome. My
mentorship team includes experts in these fields as well as in nutrition, oncology, and computational modeling.
With the dedicated support of these experts and targeted didactics, I believe this award would accelerate my
transition to an independent investigator.

Public health relevance
PROJECT NARRATIVE The gut microbiome affects many aspects of human health including aging and response to cancer treatments. Though the microbiome is malleable, we lack the knowledge to rationally manipulate it to modify older adults’ treatment response. This project will define the microbiomes of older adults with lung cancer who best respond to immunotherapy treatment, and use dietary interventions and preclinical models to define how to manipulate the microbiome to increase healthspan.